Single-Molecule Imaging for Cell Biology and Super-Resolution Microscopy

Project Summary
The cellular environment is both powerful and complex, depending both on structural organization from
the micron scale down to the nanometer scale, as well as on the dynamic time-dependence of a huge array of
enzymes, the nanomachines of the cell, and their work on proteins, oligonucleotides, and small molecules.
Visible fluorescence microscopy has been a useful tool capable of non-invasively exploring cellular behavior, but
the diffraction-limited resolution of conventional imaging has severely restricted the information obtainable on
structures on a scale below ~200 nm. Because the primary biomolecular players in cells are in the size range
on the order of 10 nm, comprehensive measurements are needed on this size scale in living systems. Super-
resolution microscopy, either based on single-molecule fluorescence imaging and control of the emitting
concentration, or on stimulated emission depletion, has solved this problem by enabling access to nanoscale
position information down to the 10-40 nm regime and below. In addition, the complementary method of single-
molecule tracking provides access to the details of motions of cellular components such as motor-driven
transport or the motion of DNA or RNA. Combined with advanced three-dimensional (3D) imaging, single-particle
tracking allows the full motion of specific cellular players to be observed in their actual context at high speed. It
is a primary thrust of this work to develop and enhance both 3D super-resolution imaging and 3D single-particle
tracking in cells by pushing the boundaries of both approaches and inventing new strategies to overcome
technical limitations, which will lead to unprecedented spatial and temporal information in fixed and living cells.
Research in the Moerner laboratory broadly seeks to address the limitations of super-resolution imaging
and single-particle tracking in cells by physical and mathematical analysis as well as by invention of new
methods. The deep motivation here is to ask the fundamental question: how can the information available from
each single molecule be maximized? Two key new microscopes are under development: 3D imaging over large
axial ranges using pupil plane phase modulations and a tilted light sheet, and a correlative method to use
cryogenic single-molecule fluorescence localizations to annotate cryo-electron tomography reconstructions.
The methodological developments of this research will be applied to a variety of critical problems in cell
biology by continuing established collaborations and by developing new collaborations with well-known
biologists. The bacterium, Caulobacter crescentus, remains as a useful model system for cellular development
needing elucidation of the superstructures and motions of biomolecules to understand the origins of asymmetric
division. The Toxoplasma gondii parasite is another fascinating organism which needs exploration with super-
resolution methods. The organization of chromatin on all scales remains to be fully understood. These and other
cell biology questions with implications for both normal and diseased function will be explored by the application
of the advanced imaging methods of this research program.

Public health relevance
Project Narrative By combining new methods for three-dimensional high precision optical imaging in living cells with careful analysis of how single-molecule labels interact with light, this research will yield develop and validate a powerful three-dimensional microscope both for super-resolution imaging as well as single-particle tracking in living cells, and the advanced imaging capability will be applied to the understanding of the numerous nanometer-sized machines such as enzymes and proteins which interact in complex ways with DNA and RNA in the cell. Having unprecedented and highly quantitative spatial information about the structures and motion of RNA, DNA loci, protein superstructures, or other biomolecules in cells down to the 10-20 nm level of precision in three dimensions with high time resolution will directly affect the understanding of biotechnological and biomedical problems which depend upon natural or aberrant cellular mechanisms. The ability to specifically and noninvasively measure high resolution structure (i.e. optically and also correlated with electron microscopy) as well as to record precise time-dependent positions of key biomolecules in live cells will have strong implications for biomedical imaging and understanding of both bacterial cell mechanisms as well as mammalian cells whose internal structures and behavior are altered in the progress of disease.